PREPARATION OF REVIEW ARTICLES & BOOK CHAPTERS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Publication of results is a fundamental aspect of scientific research in an academic setting. In this SPID, we highlight book chapter and review articles published by Resource staff.